Comprehensive Training Program in Oral Biology

In response to PAR-20-056 from the NIDCR to develop and enhance the Dental, Oral and Craniofacial
Research Workforce, a T90/R90 Comprehensive Training Program in Oral Biology is proposed. The proposal
builds on 29 years of experience with highly productive T32 and T90/R90 Training Programs at the University
of Florida College of Dentistry (UFCD) and will provide extensive breadth and depth in training to basic and
clinician scientists in multiple areas that are designated as high priority by the NIDCR. The scientific areas
encompassed in this Comprehensive Training Program in Oral Biology include, but are not limited to, the
Human Microbiome, Oral Infectious Diseases, Mechanistic Connections between Oral and Systemic Health,
Virology, Salivary Gland Biology, Autoimmunity, Bone Biology, Head and Neck Cancers, Computational
Biology, Biomedical Engineering, and Stem Cell Biology. To accomplish our goals, a team of accomplished
basic and clinical researchers has been assembled to provide an extensive set of training experiences in the
biomedical sciences that are directly relevant to oral health and diseases. Well-established interdisciplinary
research training programs in the UFCD and the UF College of Medicine will be utilized, with particular
emphasis on the Interdisciplinary PhD Program in Biomedical Sciences and the UF Clinical and Translational
Science Institute (CTSI). Trainees will include i) 3 traditional PhD students conducting oral health-related
research, ii) 4 dual-degree candidates in our DMD-PhD program, iii) 2 post-doctoral scientists (T90; PhD,
DMD/DDS-PhD, DMD/DDS), and iv) 1 non-citizen, non-permanent resident DMD-PhD holders seeking
advanced post-doctoral training (R90) to prepare them for careers in academic dentistry. In most cases, PhD
and postdoctoral trainees will receive an initial commitment for appointments of three or two years,
respectively, whereas dual-degree students will be supported for the duration of their training. Additional formal
training in Clinical Investigation, Implementation Science or Biomedical Informatics will be available to
individuals supported by the program. The use of combinations of our extensive educational, scientific, and
clinical resources has allowed us to develop highly integrated yet sufficiently flexible training options to meet
the needs of a very diverse group of trainees. Collectively, these programs will produce highly skilled and
interactive scientists who can engage in team science to generate new knowledge and translate discoveries to
tangible advances in the detection, prevention, treatment and cures of diseases and abnormalities of the oral
and craniofacial complex.

Public health relevance
There is a critical need for a diverse group of highly trained basic and clinical oral health researchers. If effective preventive therapies and cures for the many diseases associated with the oral, dental and craniofacial complex are to be discovered and applied, a cadre of oral health researchers must be trained to work in interdisciplinary teams and to maintain the highest standards for ethical and responsible conduct of rigorous scientific research. The main objective of this comprehensive training program is to produce oral health researchers who can apply state-of-the-art technologies to generate new knowledge, translate that information to applied therapies, and rigorously evaluate the outcomes of implementation of novel preventive or treatment strategies to improve human health.